NUTRITIONAL MANAGEMENT OF CHILDREN W/MULTIPLE FOOD ALLERGIES/OLIGOANTIGENIC DIET

Ross Products Division has developed a complete pediatric elemental formula (PEF) suitable for feeding to children on allergen free diets. The product is based on free amino acids and meets the recommended dietary allowances (RDA) for the 1 to 3 year old child in 10000 kcal and for the 4 to 6 year old child in 1500 kcal. The purpose of this study is to assess whether PEF will support adequate growth, tolerance and biochemical response in children requiring an elemental formula as their primary source of nutrition for 4 months while maintaining the appropriate allergen avodance diets. The primary indicators used to test the research hypothesis will be weight, height, intake, stool patterns, and blood biochemistries (serum albumin, ferritin, transthyretin, retinol binding protein [RBP], retinol and urea nitrogen, and plasma amino acids). Secondary variables will include allergic and gastrointestinal symptoms. Subjects will be children with documented AEG currently maintained on NeoCate or NeoCate 1 as their primary feeding.